LONG QT SYNDROME--GENETIC ASPECTS

The proposed research is a multidisciplinary, multicenter, collaborative study to investigate the clinical, cardiac, and genetic aspects of the Long QT Syndrome (LQTS) - a heritable disorder with delayed repolarization, episodic malignant arrhythmias with syncope and sudden death, and recently demonstrated gene linkage in a large pedigree. The five-year research plan consists of: l) resolution of the question of genetic heterogeneity in LQTS by testing for Harvey ras-1 gene linkage in the existing well-characterized LQTS families; 2) exploration by segregation analysis of the likelihood that a second gene coexists with the Harvey ras-l gene to explain a more malignant disease process in some LQTS families than in others; 3) establishment of normal standards for 6 quantitative repolarization parameters on a healthy population (n=4,000) using digitized ECG recordings, and biomedical and statistical techniques with adjustment for age, gender, race, and heart rate; 4) continuation of existing LQTS registry with on going enrollment of new families and follow-up of new and existing LQTS pedigrees (n=349 families) in order to provide a central repository for this disorder, especially as it relates to ongoing genetic analyses; 5) investigation of the static (12-lead ECG) and dynamic (24-hour Holter ECG) aspects of ventricular repolarization in LQTS families showing Harvey ras gene linkage to determine if there is a distinctive repolarization abnormality in those with the Harvey ras- 1 gene compared to those without it; and 6) continuation of the prospective longitudinal follow-up study of LQTS families to better understand the long-term clinical course of this disorder; time-dependent survivorship analyses will be performed to evaluate the effects of various clinical features, repolarization severity (QTc length), Harvey ras-l gene linkage, and therapeutic efficacy with antiadrenergic therapy (if data permits) on outcome event rates (syncope and sudden death) in the LQTS population. This integrated research program offers a substantial prospect of: 1) improving the diagnosis and treatment of LQTS; and 2) providing a fundamental understanding of the molecular basis of repolarization-related cardiac arrhythmias.